USE OF COBALT COMPOUNDS TO OBTAIN TEMPERATURE INFORMATION IN RAT LIVER

The purpose of this study is to measure temperature changes usinga functional imaging agent based on direct detection of thecobalt-59 nucleus. The strong temperature dependence of thechemical shift of cobalt compounds has primarily been determined.The goal of this work is to utilize a non-toxic cobalt compoundencapsulated in liposomes to eventually measure temperaturechanges in vivo.